Pulmonary Immune Regulation of Lung Injury after Pediatric Hematopoietic Cell Transplant

Project Summary/Abstract
Allogeneic hematopoietic cell transplantation (HCT) can be a curative treatment for children with leukemia,
immunodeficiencies, and other life-threatening conditions. However, infection, chemotherapy toxicity, and
alloreactivity can lead to post-HCT lung injury in up to 40% of children, which is a major driver of morbidity and
mortality. Paradoxically, patients exhibit high levels of systemic inflammation, yet also show limited ability to
contain pulmonary infections, suggesting a multifaceted state of both immune activation and dysfunction. Despite
this complexity, the clinical diagnosis of post-HCT lung injury largely relies on indirect or non-specific signs and
symptoms such as cough, fever, radiographic opacities, and blood-based measures of inflammation. Thus, a
major gap in the field is the limited understanding of lung-specific immune signaling that drives the progression
and hinders the resolution of post-HCT lung injury. The goal of this proposal is to elucidate lung-specific immune
pathways driving post-HCT lung injury in order to identify cellular and molecular targets for precision diagnostics
and therapeutics. To do this, we will leverage bronchoalveolar lavage (BAL) fluid and paired blood samples
obtained from pediatric HCT patients as well as non-HCT controls. In Specific Aim 1, we will elucidate peripheral
blood correlates of post-HCT lung injury. Here we will contrast cross-site transcriptomes and identify pulmonary
vs. extrapulmonary contributors to patient mortality, with each patient serving as their own control. To support
the development of a diagnostic test, we will measure alveolar peptidomes and test whether key BAL hub
proteins can discriminate lung injury subtypes when measured in blood. In Specific Aim 2, we will determine key
pulmonary immune cell populations associated with subtypes of post-HCT lung injury. We will use flow cytometry
and single cell RNA sequencing of BAL cells to determine key lineages and transcriptional states that define
lung injury subtypes and predict outcomes. Immune cells will be further characterized as marrow-derived vs
tissue-resident and of patient vs. allograft origin to unravel the specific cellular drivers of post-HCT lung injury.
Finally, in Specific Aim 3, we will evaluate the functional capacity of pulmonary mononuclear phagocytes and
test for reversibility of hypo- and hyper-activation using ex vivo stimulation. Here, patient mononuclear
phagocytes will be stimulated with lipopolysaccharide and interferon gamma and response will be assessed by
cytokine production levels and single cell transcriptomes. We will test for the reversibility of hypo and hyper-
secretory response with addition of GM-CSF and IL-10, respectively. Together these experiments will elucidate
the pulmonary-specific immune mechanisms that drive post-HCT lung injury. These results will support the
development of the next generation of BAL and blood-based diagnostic tests and will identify cellular and
molecular targets that may be leveraged for precision therapeutics in this vulnerable population.

Public health relevance
Project Narrative Approximately 100,000 hematopoietic cell transplants (HCT) were performed globally in the year 2020 as treatment for cancers, immunodeficiencies, blood disorders, and other life-threatening diseases. After HCT, injury to the lungs due to infection, chemotherapy, or inflammation can lead to difficulty breathing, reduced quality of life, and premature death. This proposal aims to improve our understanding of how the pulmonary immune system controls lung health after HCT, which is crucial for developing targeted diagnostic tests and lung-specific treatments to help improve overall HCT outcomes.